Decoding the Mechanisms for Selective Retinotectal Circuit Wiring

PROJECT SUMMARY
The precise assembly of neural circuits is crucial for understanding the functioning of the nervous system.
While studies have shed light on the molecular and cellular mechanisms behind various aspects of neural
development, such as neurite outgrowth and synaptogenesis, the mechanisms governing synaptic specificity in
the mammalian central nervous system are not fully understood. The early visual processing pathways provide
an excellent model to understand these questions in vivo. The eyes convert visual features into electrical
signals and inform the rest of the brain through diverse but precise wiring. The connections from the retina to
brain targets provide the structural basis for the circuit processing of different visual features.
Our research focuses on understanding how retinal neurons select their synaptic partners in the brain,
using the mouse retinotectal synapses as a model. By investigating the wiring of the retinotectal circuit, we aim
to gain insights into how specific visual features are regulated from the retina to the superior colliculus. We
hypothesize that each neuronal subtype has a unique repertoire of cell-recognition proteins, which determine
compatibility with circuit partners and establish synaptic contacts at specific subcellular locations. Our recent
work with transsynaptic tracing and single-cell RNA-Seq revealed selective neuronal outputs, indicating the
involvement of specific cell adhesion molecules in synaptic specificity. We have developed tools for genetic
and viral tracing and established electrophysiology-based circuit mapping assays to further our research.
Our proposed aims include determining the mechanisms by which specific cell adhesion molecules
instruct synaptic choice and wire up connections in the retinotectal circuit. First, we will focus on investigating
the mechanisms regulating convergent pathways from the retina onto Wide Field Neurons based on our past
publications. We aim to understand Npnt and Cdh13’s distinct function in vivo by linking neuroanatomy to
retinotectal circuit functions. Second, we will focus on Cdh7, a specific Type II Cdh in wiring up the retinotectal
circuits from ON-OFF Direction-Selective Ganglion Cells to Stellate Neurons in the superior colliculus, which
may reveal the role of Type II Cdhs in the retinotectal circuit assembly. Methods established here may be
applied to other parallel retinotectal circuits. These studies will be a major step forward in understanding how
multiple genes interact to specify the wiring of complex neural circuits. This research has the potential to
advance our understanding of neural circuit assembly and may have implications for understanding other
circuits in the mammalian central nervous system. This project will lay the groundwork for understanding how
cell-cell recognition regulates retinotectal circuit wiring, with insights into treatment for ophthalmological and
neurological disorders.

Public health relevance
PROJECT NARRATIVE The mammalian central nervous system is made up of many different types of neurons that form specific connections, enabling complex neural processes such as the detection and processing of visual features. We aim to use the connections between the mouse retina and superior colliculus as a model to study the role of the cadherin family of cell recognition molecules in the wiring of the retinotectal circuit. Our overall objective is to gain insight into the principles governing cadherin-mediated connectivity in the early visual pathway, to understand how neurons are organized in the central nervous system, and, ultimately, to develop new treatments for diseases affecting the eye and the brain.